2023 Neurobiology of Cognition Gordon Research Conference & Gordon Research Seminar

Project Summary
The Gordon Research Conference (GRC) on the Neurobiology of Cognition has been a flagship meeting for
this highly interdisciplinary field since its inception in 2010. The 2024 convocation will be the seventh meeting
in the series. The conference will be preceded by the Gordon Research Seminar (GRS) on the Neurobiology of
Cognition topic, geared toward graduate students and postdoc attendees. The conference brings together
leading experts with early-career scientists and trainees for a weeklong experience characterized by both
cutting-edge research presentations and relaxed interactions. The subtitle, and therefore focus of the 2024
Neurobiology of Cognition GRC is “Exploring the Mechanisms of Cognition: Insights from Neuroscience and
Computation”. Broad topics to be covered include attention, memory, decision-making, perception, and action.
Introduced to the itinerary this year are three new sessions: one topic devoted to the impact of emotion on
cognition, another focused on social communication among primates, and a third on computational models of
cognition. In addition, GRC speakers are encouraged to present and emphasize cutting-edge laboratory
techniques. Twenty-eight invited speakers will join approximately 120 trainees for the weeklong conference.
The GRC format fosters camaraderie by assuming all attendees will participate for the entire week, and invited
speakers will remain for the entire conference, with exemptions reviewed on a case-by-case basis. The 9 GRC
sessions begin with the first session Sunday evening, and two per day Monday – Thursday, with daily meals
held together and free time in the afternoon, so there is ample time for recreational activities and informal
scientific discourse. The structure of this meeting helps to break down career rank barriers, and this can be
particularly beneficial for female trainees and trainees from under-represented backgrounds. The organizers of
the GRC and GRS will make extensive efforts to select speakers who represent a diversity of perspectives.
Priority for acceptance to the attend the meeting and for funding support will be given to trainees who are
women and/or from under-represented groups. Through its 12-year history, the Neurobiology of Cognition
GRC has helped to grow this field and has fostered career growth and new collaborations. The chairs of the
GRS and GRC expect the 2024 meeting will be another successful rendition of this flagship meeting for our
field.

Public health relevance
Project Narrative The 2024 Gordon Research Conference on the Neurobiology of Cognition, the seventh meeting on this theme, will bring together leading experts and trainees for a weeklong meeting designed to foster growth and collaboration in this exciting field. The conference will be preceded by the Gordon Research Seminar on this topic, geared toward graduate student and postdoc attendees. Topics to be discussed at these events include key aspects of cognition such as attention, memory, perception, action, and new this year, affect and communication.